Evaluation Core

PROJECT SUMMARY EVALUATION CORE
NeuroTech Harbor's (NTH) Evaluation Core (EC) is a critical element of the NTH. The EC will be responsible
for providing thorough, timely evaluations of a large number of innovator proposals and identify those few that
have a high potential for clinical impact and commercial viability. In addition, the EC will identify gaps in proposals
that help innovators improve, as well as guide future steps on reapplying to NTH or other BP Hubs. The EC must
not only ensure that the need addressed in a proposal is significant, but also that a feasible plan is viable and
laid out to achieve deliverables, including resources required. Since NTH will receive a broad range of
applications, the EC will recruit top experts to adequately evaluate proposals. Finally, the EC will recruit experts
from diverse backgrounds, a core value of NeuroTech Harbor. Lastly the EC will assess and provide guidance
in ways innovators can increase the potential for commercial success globally by expanding their impact to
under-served communities.
To help manage this complex task, the NTH EC will leverage the Consortia for Improving Medicine with
Innovation & Technology's (CIMIT's) Guidance and Impact Tracking (GAITS) web-based platform to (i) help
innovators prepare competitive proposals, and (ii) provide a methodology for all EC panels, especially the Deep-
Dive panel, to assess subproject proposals with consistent criteria. The EC will provide applicants and panel
members with basic training on how to use the GAITS platform. To recruit diverse specialists covering topics of
all submitted proposals to serve on our evaluation panels, the EC will work with NTH's Consultant Network, and
leverage The LaunchPort, a MedTech manufacturing accelerator, with an extensive network of diverse experts.
The EC aims are: (Aim 1) To implement a rigorous, unbiased, and efficient evaluation process that identifies
neuromedical solutions with high potential for commercial success and clinical benefit. (Aim 2) To deploy a
proposal management platform to facilitate evaluation of subproject and subaward proposals as well as
preparation of proposals. (Aim 3) To facilitate building a pipeline of diverse aspiring innovators. The evaluation
process is inspired by the RADx model and the NIH peer review system and will include industry experts who
will appraise the feasibility of the total lifecycle of proposed solutions. Evaluation will occur in three stages: Triage,
Viability, and Deep Dive. Short preproposals will be evaluated during Triage, and full proposals will be evaluated
during Viability and Deep Dive. Full proposals will be assessed using GAITS criteria and NTH's new equity &
accessibility criteria. The Deep Dive stage will involve intensive interaction and multiple feedback cycles with
proposers and reviewer. To facilitate evaluation and management of subproject and subaward proposals,
NeuroTech Harbor, in partnership with VentureWell (VW), will provide an online portal for applicants to submit
their applications and for reviewers from the EC, Steering Committee, and NIH personnel to review and comment
on proposals.